pH regulation of cell surface receptors

ABSTRACT
Understanding proton-gating (H+-gating) of GPCR activity is a major new frontier in signaling biology.
GPCRs regularly encounter coincident H+ signals in a variety of contexts, such as endosomes, tumors,
synapses, inflamed tissue, and immune responses. However, the extent to which these signals regulate
GPCR function represents a significant gap in our understanding of cellular sensing, communication, and
drug discovery. The goal of our research program is to provide this insight for much of the GPCRome.
A major goal is the development of pH-intelligent nanobodies that enable the direct tracking and
regulation of GPCR function in normal and acidified conditions, with a longer-term plan is to develop the
most promising of these precision tools into therapeutics. We have had much success in these efforts.
We have successfully engineered the necessary nanobody discovery platform and validated it using
known GPCR-nanobody pairs. We have also computationally designed and manufactured new synthetic
nanobody libraries which we have begun to screen against pools of diverse GPCRs. Because of our
large library sizes and high hit rates, we have discovered a bottleneck in the plating, cataloging, picking,
and characterization of yeast colonies carrying putative nanobody hits. The instrument we are requesting,
a Mini Qpix small footprint microbial colony picker, will overcome this bottleneck and enable us to expand
our processing from hundreds to thousands of nanobody hits. Such capabilities would greatly accelerate
the discovery of nanobody regulators of GPCRs and have the potential to illuminate nanobody diversity
at a depth and scale necessary for training artificial intelligence algorithms for de novo nanobody design.
As such, NIGMS support for our instrument request would catalyze a substantial leap forward in the field.

Public health relevance
PROJECT NARRATIVE The parent program for this request (R35GM119518) seeks to understand proton-gated coincidence detection by G protein-coupled receptors (GPCRs), the largest and most therapeutically targeted class of transmembrane receptors in humans. A major program focus is the development of pH-intelligent nanobodies that enable the study and direct regulation of GPCRs in normal and acidified conditions. We have built this platform but have encountered an unforeseen bottleneck in our discovery pipeline. The requested Qpix colony picker will overcome this bottleneck to accelerate and broaden our efforts.